Cannabidiol as a treatment for alcoholic liver disease

ANSTRACT
Cannabidiol (CBD) is the major non-psychoactive cannabinoid in cannabis. Recently US FDA has
approved Epidiolex, an oral CBD formulation, for the treatment of two forms of pediatric epileptic syndromes. In
addition, CBD is currently in clinical trials for a variety of diseases. Two recent studies have demonstrated that
intraperitoneal injection of CBD to mice in a binge-on-chronic alcoholic liver disease (ALD) model alleviated
liver steatosis, metabolic dysregulation, oxidative stress, inflammation, and neutrophil-mediated injury,
indicating CBD has protective potentials against ALD. However, it is unknown if CBD can be administered
orally to achieve its protective effects against ALD, and if CBD has therapeutic, in addition to its preventive
potentials against ALD. Furthermore, intestinal mechanisms underlying the protective effects of CBD against
ALD is unknown.
GPR3 is an orphan G protein-coupled receptor (GPCR) recently identified by us to be a novel CBD
receptor. In preliminary studies, we found that GPR3 is upregulated in the ileum of mice fed with alcohol.
Furthermore, our preliminary data demonstrated that CBD enhanced the level of claudin-1 and significantly
inhibited alcohol-induced barrier dysfunction in intestinal epithelial Caco-2 cells. These preliminary data
suggest that by acting on GPR3, CBD may restore the intestinal barrier function disrupted in ALD. Aryl
hydrocarbon receptor (AhR) is a ligand-activated nuclear receptor expressed in intestinal type 3 innate
lymphoid cells (ILC3). Recent studies by us and others have demonstrated that AhR ligands such as
tryptophan metabolites from beneficial bacteria protect against ALD in mouse models through the intestinal
AhR-IL22-Reg3 pathway. Interestingly, recent reports have identified CBD as a ligand for AhR with therapeutic
potentials. These previous studies imply that CBD may exert its protective effects against ALD through
intestine AhR to ameliorate intestinal barrier dysfunction and gut dysbiosis.
Previous literature and our preliminary studies provide the foundation for our central hypothesis for this
R21 project: oral CBD treatment has preventive and therapeutic potential against ALD through intestinal
GPR3- and/or AhR-mediated restoration of gut barrier function and eubiosis. Two aims are designed to test our
hypothesis: (1) To investigate the potential therapeutic effects of oral CBD against alcohol-induced gut
microbiota dysbiosis, intestinal barrier dysfunction, and liver injury. We will use a chronic alcohol feeding
mouse model in this aim. (2) To explore the potential GPR3- and AhR-mediated mechanisms underlying the
effects of oral CBD against alcohol-induced intestine and liver injury. We will use both GPR3 knockout mice
and intestinal ILC3 specific AhR knockout mice to test our hypothesis. Completion of this study is expected to
significantly impact the development of oral CBD in the treatment of alcohol-associated liver diseases.

Public health relevance
NARRATIVE Cannabidiol (CBD) is the major non-psychoactive cannabinoid in cannabis. We will study the potentials and mechanisms of oral CBD in treating alcoholic liver disease (ALD). Completion of this study will help to develop a new treatment of ALD using CBD, which is generally safe to use and has already been approved by US FDA for other indications.